Center for accelerated development of drug candidates targeting high threat bacterial infections

SUMMARY
The global rise in antimicrobial resistance (AMR) poses a grave public health threat, limiting treatment options
and causing substantial morbidity and mortality. Particularly concerning is the rise of AMR among both Gram-
negative (GN) and Gram-positive (GP) bacterial pathogens in hospital and community settings. Addressing this
urgent medical need demands the development of effective new antibiotics targeting high-threat AMR
pathogens, yet the current pipeline's capacity to meet this demand is insufficient. With antibiotic development
now predominantly driven by biotech, academia plays an increasingly pivotal role in collaborating with industry
to foster the development of clinically viable drug candidates. Our Center of Excellence in Translational Research
(CETR) drug accelerator was established to leverage the expertise of five seasoned drug developers from
academic (CDI, Rutgers) and pharmaceutical/biopharmaceutical (Merck, Prokaryotics, BioVersys) sectors.
This collaborative effort aims to advance mature antibacterial small molecule inhibitor programs through
preclinical development, resulting in multiple IND submissions for clinical assessment. Our focus is on
combating clinically significant, high-threat, drug-resistant bacterial pathogens including GP: nontuberculous
mycobacteria (NTM) Mycobacterium abscessus and Mycobacterium avium; methicillin resistant Staphylococcus
aureus, and Enterococci; fastidious GN: Neisseria gonorrhea, Haemophilus influenzae, Moraxella catarrhalis,
Legionella pneumophila, Chlamydia pneumoniae, and Mycoplasma pneumoniae, and non-fastidious GN
pathogens: Acinetobacter baumannii and Burkholderia spp by prioritizing development of both narrow- and
broad-spectrum small molecule inhibitors targeting key enzymes and prominent pharmacological targets. All of
our Projects are advanced with mature compounds representing new chemical classes that can overcome
existing mechanisms of resistance and are poised to be developed as preclinical development candidates. The
CETR includes an integrated network of science cores staffed by experienced directors, facilitating efficient
compound identification and optimization. Clear criteria for compound progression with ‘go, no-go’ metrics have
been established to ensure streamlined development processes. The CETR fosters synergy among Projects,
developing distinct drug candidates targeting overlapping threat agents. By bringing together highly
accomplished Project leaders and partners from academia and industry, supported by experienced Core leaders,
world-class Scientific Advisory Board members, and regulatory specialists, we will effectively navigate preclinical
development stages, swiftly advancing optimized leads through rigorous milestones as preclinical development
candidates for IND-enabling and de-risking studies. The goal of our efforts is to develop multiple preclinical
development candidates suitable for IND submission. Strong industry collaboration facilitates downstream
clinical development for select Projects, while others are poised for licensing or partnership with
biopharmaceutical companies. Through our concerted endeavors, we strive to address the critical need for new
antibiotics to combat the growing threat of antimicrobial resistance.

Public health relevance
NARRATIVE The escalating antimicrobial resistance crisis poses a grave threat to public health, diminishing treatment options and escalating morbidity and mortality rates. The emergence of highly resistant bacteria underscores the urgent need to expedite the development of novel antibiotic candidates capable of addressing this pressing global challenge. Our focused objective is to accelerate five advanced lead programs with academic-industry partnerships, culminating in the creation of multiple investigational new drugs tailored for clinical evaluation, aiming to effectively combat the persistent threat of antimicrobial resistance.